Regulation of Cardiac Metabolic Plasticity in Sepsis

Project Summary
Sepsis is a leading cause of death in critical care units. The long-term goal of my
research is to understand the mechanisms of sepsis-induced multi-organ failure and to
identify potential new therapeutic opportunities for this devastating clinical condition.
Studies proposed in this application are designed to elucidate novel pathological
functions of a mitochondrial metabolism regulatory kinase, pyruvate dehydrogenase
kinase 4 (PDK4), in sepsis-induced cardiomyopathy using preclinical models.
Previous studies showed that energy deficiency due to metabolic inflexibility is tightly
associated with adverse outcomes in sepsis. Ongoing investigation in my lab obtained
exciting preliminary evidence suggesting that overstimulation of PDK4 is a key causative
factor for myocardial metabolic inflexibility in sepsis, and the underlying mechanism may
involve causing impairments at mitochondria-associated membranes (MAMs), a
previously unknown signal of PDK4. We also found that cardiac specific ablation of
PDK4 is cardiac protective, suggesting that PDK4 is a promising therapeutic target for
sepsis. This exploratory project is to test the hypothesis that, during sepsis, PDK4
triggers metabolic inflexibility via pathological injuries at MAMs, leading to an insufficient,
maladaptive autophagy and overwhelming inflammation in the heart. Using both gain-of-
function and loss-of-function approaches in vitro and in vivo, we will examine whether
PDK4 induces functional deficiency and structural damage in MAMs, which in turn
produce dysfunctional mitochondria and initiate metabolic inflexibility in septic hearts
(aim 1). Further, we will address the roles of PDK4 in cardiac autophagy and
inflammation in sepsis by interrogating its regulation in the inhibition of autophagy,
production of cytokines, activation of inflammatory factors, and infiltration of immune
cells in myocardium (aim 2). Together, this investigation is expected not only to advance
the fundamental understanding of sepsis pathology but also to evaluate whether
blockage of PDK4 improves cardiac outcomes in sepsis, laying a scientific foundation for
future development of novel therapies.

Public health relevance
Project narrative: Sepsis is a deadly disease that kills approximately 215,000 Americans each year. This proposed investigation will use preclinical models to determine the mechanisms underlying sepsis-associated cardiomyopathy. Studies are designed to explore how cardiac metabolism is regulated, and therefore having a promising potential to develop novel therapies for clinical utility in the near future.